A Roadmap to Uncover RPE Plasticity

Abstract
Degenerative retinal diseases represent an enormous public health burden and demand innovative strategies to
replace retinal neurons. Ideal solutions will overcome innate barriers associated with terminal differentiation to
endogenously regenerate retinal neurons. Retinal pigment epithelium (RPE) cells hold promise for this
application, as these cells can reprogram to produce neural retina in embryonic amniotes. For reasons that are
not well understood, RPE cells lose neural competence during early amniotic development. The present study
proposes to comprehensively map the gene regulatory landscape of RPE at plastic stages of development and
to probe the molecular barriers to reprogramming that emerge as these cells differentiate. RPE cells of the
chicken are plastic at embryonic day 4 (E4) and can be reprogrammed to neural retina following retinectomy and
treatment with FGF2. However, by embryonic day 5 (E5), RPE cell fate becomes restricted and reprogramming
capacity is abrogated. Previous studies have demonstrated that E4 RPE cells reprogram through the activation
of neural retina transcription factors, such as VSX2, SIX6, and PAX6, and the simultaneous repression of RPE
differentiation programs. Concomitantly, an epigenetic reprogramming event resets DNA methylation and poises
chromatin into a more active configuration to facilitate the ensuing change in cell identity. However, it is not
understood how transcription factor networks interact with a dynamic chromatin landscape to determine RPE
neural competence. Our preliminary evidence suggests that pro-neural genes remain comparably inducible in
the E5 RPE, but that an incipient RPE differentiation program serves as an inherent barrier to neural identity at
this stage. This differentiation program is led by the RPE transcription factors MITF and OTX2, and distinct
accessibility footprints from these factors are observable in the chromatin landscape. The current proposal will
build on these findings by mapping genome-wide epigenetic patterns associated with RPE competence
restriction, including DNA and histone modifications that have been previously demonstrated to facilitate RPE
reprogramming (Aim 1). Additionally, RPE differentiation and reprogramming will be profiled at a single cell
resolution, enabling the precise identification of transcriptomic features that delineate plastic and fate restricted
RPE (Aim 2). In parallel, the DNA binding activity of key effector transcription factors, such as MITF and OTX2,
will be profiled across the RPE at different stages of differentiation or reprogramming. These factors, as well as
key transcriptional targets, will be perturbed using CRISPR-Cas9 with the intention of recovering RPE neural
competence at more advanced stages of differentiation (Aim 3). Together, these findings will provide an
expansive view of chromatin states associated with RPE competence restriction, while simultaneously probing
the chromatin – transcription factor interactions that drive the observed phenotypes. These results will provide
imperative insights toward understanding RPE differentiation and the potentiality of this cell type for use in neuron
replacement strategies.

Public health relevance
Project Narrative A longstanding goal of retinal restoration therapies is to devise methods that enable the replacement of retinal neurons from endogenous cell sources. Embryonic retinal pigment epithelium (RPE) cells have a transitory ability to regenerate retinal neurons, but as RPE cells mature they lose their neural competence. The proposed study will leverage multi-modal data analysis to interrogate the molecular foundations of RPE cell identity, with the intention of recovering the regenerative potential of RPE cells at advanced stages of differentiation.